Basic and Translational Research Training in Pediatric Classical Hematology

PROJECT SUMMARY
Non-malignant blood disorders affect millions of individuals worldwide. Studies of these diseases and normal
hematopoiesis (i.e. Classical Hematology) contribute to our general understanding of normal tissue
development, mechanisms of gene expression, and medical genetics. Indeed, sickle cell disease, the first
“molecular disease”, is the first disorder to be FDA-approved for therapeutic genome editing. More than 120
genes regulating virtually all fundamental cellular processes have been implicated in the mechanisms of
inherited bone marrow failure (BMF) syndromes, and investigations of myeloproliferative neoplasms (MPNs)
have advanced our understanding of cytokine receptor signaling. Despite these advances, non-malignant
blood disorders remain a major health problem, warranting the development of new effective therapies.
Progress towards this is hampered by a critical shortage of biomedical trainees focused on Classical
Hematology. Our proposed training program addresses this critical shortage by attracting trainees to the field
and equipping them with the excitement, knowledge, and skills to make new biological discoveries. St. Jude
Children’s Research Hospital’s commitment to trainee education, focus on advancing cures for pediatric
Classical Hematology disorders, and exceptional resources for biomedical research support this goal. Our
program will support three postdoctoral fellows with enriched training in basic and translational Classical
Hematology, focusing on hypothesis-driven research that aims to elucidate the mechanisms of non-malignant
blood diseases and uncover new therapeutic targets. Trainees will employ state-of-the-art -omics technologies,
genome engineering, in vitro and in vivo models of hematologic disease, and rigorous statistical testing to
accomplish their research goals. The program is supported by faculty with diverse expertise, a mentorship
committee for each trainee, an Internal Steering Committee to advise on program development and training
activities, and an External Advisory Board comprised of five national leaders in Classical Hematology. Training
elements include a dedicated lecture series, opportunities for relevant clinical exposure and education, a
quarterly discussion series devoted to career development, a Training Day that includes trainee and invited
speaker presentations, a grant writing workshop, and individualized mentoring committees and career
development plans with detailed evaluation of trainee progress. This program will expand the pool of highly-
qualified future leaders in laboratory-based Classical Hematology research.

Public health relevance
Project Narrative The St. Jude Children’s Research Hospital's Pediatric Classical Hematology (PCH) T32 Program seeks to address the critical shortage of basic and translational researchers focused on understanding and treating pediatric Classical Hematology disorders. Non-malignant blood disorders affect millions of individuals worldwide and studies of these diseases contribute to our general understanding of normal tissue development, mechanisms of gene expression, and medical genetics. The PCH T32 program will motivate and prepare a diverse group of future leaders in Classical Hematology research by providing an integrated program of rigorous, hypothesis-driven laboratory training in the biology of blood formation and relevant diseases, formal mentoring in career development, and complementary exposure to clinical hematology.